Admin Core

ADMINISTRATIVE AND DATA ANALYSIS CORE: SUMMARY
The Administrative and Data Analysis Core of the Stanford U54 SARS-CoV-2 Serological Sciences Center of
Excellence will be responsible for providing overall management, data coordination, and oversight for the
Center. The Core will establish and maintain the administrative structure and functions of the U54 Center to
facilitate communications among investigators to promote their productive collaboration, and among all
Center investigators and staff to coordinate efforts, identify and resolve problems, and establish a strong
collaborative environment to achieve the aims of the U54 to combine a deep mechanistic analysis of the
adaptive immune responses of COVID-19 patients, with a focus on studying underrepresented and at-risk
patient populations, to determine the factors that result in effective and durable immunity to SARS-CoV-2
infection. This Core will also contribute to integrated data analysis of the results from all Projects and the
Clinical and Virology Core, in support of the Center’s research goals.